Chromatin regulation of cell fate transitions during cortical development

PROJECT SUMMARY/ABSTRACT
The cerebral cortex – the brain’s center for conscious perceptions, thoughts, and actions – is supported by a
myriad of cells distinct identities. These identities are established during cortical development in a temporally
organized manner: neural progenitor cells (NPCs) first give rise to deep layer neurons, then to upper layer
neurons, and finally transition into gliogenesis to produce astrocytes. To generate the correct type of cell at the
correct time, NPCs must keep track of where they are in the sequence. However, the mechanisms that directs
when NPCs transition from one production mode to another during sequential neurogenesis remain incompletely
understood. Some groups have proposed the Polycomb Repressive Complex 2 (PRC2) as a potential
mechanism. PRC2 is thought to be involved in the mitotic inheritance of the histone post-translational
modification (PTM) H3K27me3, which is associated with transcriptional repression. In fact, when essential PRC2
subunit Eed was deleted at the onset of neurogenesis, NPCs bypassed generation of late-born upper-layer
neurons and prematurely transitioned to astrocyte generation. To directly test if PRC2 is the mechanism that
transitions NPCs through the neurogenesis sequence, we first conditionally deleted Eed at the onset of
neurogenesis, then re-expressed it by in utero electroporation (IUE) at E15.5 – 5 days after conditional deletion
of Eed – when upper layer neurons are typically generated. Remarkably, re-expression of Eed in NPCs enabled
them to correctly generate upper-layer neurons appropriate for E15.5, effectively rescuing cKO phenotypes. This
surprising finding supported the possibility that temporal information successfully progressed in NPCs over the
5 days during which H3K27me3 deposition was absent. These exciting preliminary data form the basis of my
hypothesis that PRC2 is required for interpreting the correct stage of neurogenesis, but NPC temporal
progression is mediated by non-PRC2 mechanisms. Here, I aim to investigate this hypothesis by: 1)
mechanistically separating the roles of PRC2 in transcriptional repression from its functions in histone PTM
inheritance across NPC divisions; and 2) identifying non-PRC2 transcriptional mechanisms and histone PTMs
that can progress the neurogenic sequence. Together, the proposed work will delineate the roles of PRC2 in
neurogenesis, deliver developmentally-staged NPC-specific transcriptomic and functional genomic data, and
identify candidate mechanisms of sequential neurogenesis for future follow-up studies. Importantly, these studies
will provide excellent conceptual and technical training towards my long-term goal of pursuing academic research
in molecular and developmental neuroscience.

Public health relevance
PROJECT NARRATIVE During development of the cerebral cortex – the portion of the brain responsible for conscious thought, action, and perception – a myriad of diverse cells must acquire distinct molecular profiles, morphologies, connectivities, and physiologic properties. These cellular identities are specified through a tightly organized, sequential process; however, the precise mechanisms directing this process remain unclear. This project seeks to clarify the role of one potential mechanism – the Polycomb Repressive Complex 2 – in the specification of cell identities during cortical development, and to deliver a concise list of other promising candidates whose roles can be assessed in future studies.